Leadership, Planning, and Evaluation

ABSTRACT: LEADERSHIP, PLANNING, AND EVALUATION
Leadership, Planning, and Evaluation efforts of the Sidney Kimmel Cancer Center (SKCC) focus on developing
a comprehensive, inclusive system to engage Consortium Institutional Leaders, Senior Leadership, Members,
community advocates, staff, patients, and caregivers in pursuit of the SKCC mission. This effort includes well-tested
and integrated mechanisms to monitor, evaluate, and adjust the Center's Program activities, Shared
Resource services, funding allocations, and strategic directions. Planning and Evaluation ensures that future
directions are achievable, and that resources and investments are targeted effectively while providing the ability
to respond to new opportunities. SKCC's Planning and Evaluation process is highly integrated with institutional
planning and resource allocation activities across the consortium to ensure alignment and ability to capitalize on
institutional investments. Once formally appointed as Center Director, Dr. Chapman immediately identified the
development of a new five-year strategic plan, IMPACT PHL, as one of his first priorities. Consistent with his
management style, he created a transparent and inclusive planning process with high engagement throughout
the consortium including members, university and health system leaders, and other stakeholders including the
Community Advisory Board. This process was developed to augment a change of culture and effectively define
the SKCC's vision, creating a mechanism to guide decisions, assess progress, and make changes to ensure
success. The plan was completed within 6 months of his appointment and has shaped leadership investments,
recruitments, and consortium initiatives. Significant progress has already been made. In addition, the Research
Executive Cabinet (REC), comprised of senior leadership, conducts intensive annual Program and Shared
Resource reviews, through which they assess progress against goals, and cancer relevance relative to
catchment area needs. REC serves to: 1) ensure the Center Director's vision by overseeing implementation of
strategic processes that ensure effective resource allocation, development and management of Programs,
Shared Resources, and other components; 2) foster a collaborative scientific environment that facilitates high-impact
research and clinical care; 3) enable a focus on cancer problems applicable to the catchment area; and
4) develop effective training and educational programs for basic, clinical, and population researchers that
prioritize the development of a diverse and inclusive workforce. Planning and Evaluation processes serve to: 1)
develop and oversee action plans that align with the SKCC vision to achieve Center goals; 2) implement well-organized
internal, external, and institutional planning and evaluation processes that engage leaders, members,
and advisors and enable the Center to achieve goals; and 3) provide ongoing mechanisms to monitor, evaluate,
and improve Programs, Shared Resources, Developmental Funds, clinical research resources, new initiatives,
funding priorities and allocations, and strategic directions to ensure alignment with the Center's vision and goals.